Candidalysin: a key mediator of Candida vaginitis immunopathology

Candida albicans, the primary causative agent of fungal vaginitis, will affect 75% of all women of reproductive
age at least once in their lifetime. Long believed to result from immunodeficiency, a growing body of evidence
strongly suggests that vaginitis is now considered to be an immunopathology, in which the host response
actually drives disease symptoms. Lack of a comprehensive understanding of the host and fungal factors that
initiate symptomatic disease remains a significant barrier to progress in better treating and managing this most
prevalent human fungal infection. Guided by strong published and preliminary data, we have identified that the
fungal peptide toxin candidalysin is the major virulence determinant driving vaginitis pathogenesis and that
amino acid variation of this effector exists amongst C. albicans clinical isolates that impacts pathogenicity.
Therefore, the objectives of this proposal are to determine the capacity to which novel candidalysin variants
can drive IL-1 signaling during vaginitis and whether vaccination strategies and novel thiobenzoate chemical
scaffolds can block both fungal growth and/or inflammation to better resolve disease symptoms. Under the first
aim, we will determine if novel amino acid candidalysin variants observed in clinical isolates impact
pathogenicity or competitive fitness in vivo. We will also determine structure-function activity of the entire
candidalysin coding sequence by performing alanine scanning to identify non-toxic vaccine candidates that my
limit immunopathology following immunization. The second aim will focus on delineating redundant and unique
contributions of IL-1 isoforms in controlling fungal burden and driving inflammation at the vaginal mucosa and
which cell types produce IL-1 during vaginal infection. We will use a series of constitutive and conditional
knockouts to further probe which cell types respond to and govern IL-1-dependent phenotypes. The third aim
seeks to validate previously and newly identified small molecules that possess both anti-inflammatory and
antifungal activity using an established pipeline from in silico molecular docking to functional validation. The
outcomes of this project will provide foundational information regarding function of novel candidalysin isoform
variants, candidalysin-dependent IL-1 responses during vaginitis, and identify promising new chemical
scaffolds to impede IL-1 signaling that may be exploited for improved clinical management of vaginitis.

Public health relevance
Vulvovaginal candidiasis is an exceedingly common infection of the reproductive tract of otherwise healthy women that is caused by the fungus Candida albicans and significantly impacts quality-of-life. The research in this proposal is aimed to identify how natural variation in the fungal toxin candidalysin, a key determinant of disease, alters vaginal inflammation. We also aim to dissect pathological host responses to Candida and candidalysin and identify novel therapeutic interventions that may inhibit both harmful inflammation and fungal growth to improve resolution of disease symptoms.